Paramyxoviridae and Bunyavirales Vaccines and Antibodies Center (PABVAX)

PROJECT SUMMARY/ABSTRACT - Overall
Emerging and reemerging pathogenic RNA viruses represent continuous infectious disease and pandemic
threats to public health. Among the many groups of these types of pathogens are viral zoonoses within the
family Paramyxoviridae and order Bunyavirales. The Bunyavirales is composed of several viral families known
to contain several high priority human pathogens. Notably, Arenaviridae and Nairoviridae families contain
viruses which cause severe hemorrhagic diseases in humans worldwide with associated high morbidity and
mortality. A host of arenaviruses viruses, including Lassa, Machupo, Lujo, and Chapare viruses and the
nairovirus Crimean-Congo hemorrhagic fever virus and are also included among the World Health Organization’s
(WHO) List of Priority Pathogens. The zoonotic henipaviruses (HNVs) including Nipah virus (NiV) and Hendra
virus (HeV), in the Paramyxoviridae family are also on the WHO Priority Pathogens. These HNVs have a
uniquely broad host tropism, causing an often fatal respiratory and/or neurological disease, and are significant
biothreats to humans and livestock in Southeast Asia and Australia. All these RNA virus threats to global public
health are heightened due to the absence of approved vaccines or therapeutics. There is a clear unmet need
for countermeasures to address the threat of natural outbreaks, epidemics, or deliberate release. The
Paramyxoviridae and Bunyavirales Vaccines and Antibodies Center (PABVAX) is a well-integrated consortium
conducting a set of discovery and translational research programs composed of a Data Management Core, 3
Scientific Cores, and 5 Research Projects (RPs). The synergistic activities of Center partners will be focused on:
developing, testing, and translating, prototype subunit vaccines employing a novel adjuvanted dissolvable,
microneedle patch (MNP) vaccine platform; developing new virus and animal model tools; and developing and
testing monoclonal antibody and nanobody prototypes to foster pandemic preparedness. The level of team
experience in both vaccines and antibody countermeasure advancements among the RPs is a major strength
and advantage of this Center. The PABVAX Center’s overall objective is to elucidate key principles for vaccine
and antibody-based countermeasures in developing prototype candidates against a selection of these viruses.
In the out years of the effort, the Center will exploit these learned key principles in a “plug and play” approach
against related viruses.

Public health relevance
PROJECT NARRATIVE - Overall Select zoonotic RNA viruses within the Paramyxoviridae and Bunyavirales represent a continuous threat to global public health due to their ease of dissemination and/or transmissibility from person-to-person and result in significant morbidity and mortality, thus requiring special actions for public health preparedness. These viral threats to global public health are heightened due to the absence of approved vaccines or therapeutics. There is a clear unmet need for vaccines and antibody-based therapeutics to address these threats that can arise from natural outbreaks, epidemics, or bio-weaponization and deliberate release.